Siah2: an E3 ligase organizes polarity and cytoskeletal links in neuron migration

A spectrum of human neurological disorders including epilepsies, Lissencephaly or pediatric cancer
is due in part to defective neuronal motility or germinal zone (GZ) exit and the resultant errors in neuronal circuit
formation. To design strategies to prevent or treat such disorders, the field has sought to clarify the molecular
mechanisms regulating neuronal motility and migration initiation. Despite advances implicating various genes
essential for neuronal migration, a key gap in our knowledge is to discover how disparate cytoskeletal or
signaling molecules cooperatively execute complex neuronal motility programs, such as GZ exit or
nucleokinesis. My laboratory has tackled this challenge by dissecting neuronal polarity pathways impacting
neuronal differentiation, nucleokinesis and adhesion control during GZ exit using the evolutionarily conserved
Partitioning Defective, or Pard, polarity signaling complex as a molecular entry point. We gained insights into
the regulatory logic controlling polarity during cerebellar granule neuron (CGN) development by discovering that
the Seven in Absentia 2 (Siah2) E3 ubiquitin ligase is a Pard, complex antagonist. Siah2 is heavily expressed in
CGN progenitors (GNPs); but not postmitotic CGNs, where Siah2-targeting of Pard3 for degradation constitutes
an active pathway for progenitor polarity inhibition. We are uniquely positioned to discover new cellular
mechanisms that control the onset of neuronal polarity since others overlooked inhibitory pathways in the past.
In preliminary studies, we characterized new Siah2 targets relevant to GZ exit and radial migration: the
Deleted in Colorectal Carcinoma (DCC) Netrin-1 (Ntn1) receptor and drebrin microtubule-actin crosslinking
protein. Preliminary analysis shows: 1) Ntn1 stimulates CGN GZ exit and that Siah2 inhibits, while Pard3
promotes Ntn1-induced DCC receptor exocytosis, suggesting a hypothesis that Siah2-Pard3 antagonism
regulates CGN sensitivity to Ntn1 GZ repulsion possibly through a link between DCC and junctional adhesion
molecule-C (JAM-C), an adhesion receptor exocytosed in a Pard3-dependent manner. 2) Drebrin links actin-
microtubule dynamics that are in turn regulated by Siah2 ubiquitination, suggesting a hypothesis that Siah2-
drebrin antagonism governs the onset of nucleokinesis via microtubule-actin interactions. Remarkably, Siah2
expression is enhanced in Lissencephaly 1 (Lis1) deficient CGNs and Siah2 loss of function (LOF) or drebrin
gain of function (LOF) rescues Lis1LOF migration phenotypes, suggesting that altering the balance of
microtubule-actin interactions could have therapeutic value in classic neuronal migration disorders.
We will build on our expertise examining polarity signaling in neuronal migration to combine in vivo genetics
and ex vivo mechanistic studies with the power of transformative imaging technologies like Lattice Light Sheet
Microscopy (LLSM) live-cell imaging to explore the following aims:
Aim1: Define how Siah2 and Pard3 regulate DCC-dependent Ntn1 GZ repulsion.
Challenge: Our current understanding of how guidance cues are interpreted in conjunction with cell adhesion
and neuronal polarity pathways is limited. The findings that Siah2-Pard3 antagonism regulates DCC trafficking
through a link to JAM-C adhesion sites presents an unique opportunity to test the premise that an adhesion and
guidance receptor coincidence detection circuit control migration initiation.
Approach: We will ablate DCC and Ntn1 in GNPs to confirm GZ repulsion in vivo. We will use epistasis in ex
vivo slices or Ntn1 gradients in combination with mechanistic live-cell imaging, including LLSM, to assess how
Ntn1 sensitivity couples to migration path selection via Siah2 antagonism of Pard3, DCC and JAM-C.
Impact: Aim 1 will provide a new conceptual model for how polarity inhibition regulates GNP GZ occupancy
and how relief of inhibition in postmitotic CGN stimulates GZ exit through adhesion and guidance receptors.
Aim 2: Determine how Siah2 regulates microtubule-actin interactions during neuronal differentiation
and Lis1-deficient CGNs.
Challenge: Our current understanding of how cytoskeletal systems cooperate to execute radial migration or
how these interactions fail in migration disorders is poor. Our findings that Siah2 regulates drebrin-dependent
microtubule-actin interactions and Siah2LOF rescues Lis1LOF migration defects presents an opportunity to test
two premises: 1) enhanced cytoskeletal interactions during CGN differentiation regulate the onset of classic
nucleokinesis and 2) enhanced microtubule-actin restore migration in Lis1-deficient CGNs.
Approach: We will use in vivo genetics, an ex vivo epistatis screen and live-cell imaging assays to assess how
Siah2 mechanistically controls microtubule-actin interactions in normal or pathologic forms of CGN migration.
Impact: Aim 2 could provide a new conceptual model of how the cytoskeletal interactions that drive neuronal
motility are elaborated when neuronal progenitors transition to postmitotic neurons and may open the potential
to exploit these mechanisms to further understand neuronal migration disorders.
The proposed studies will also provide key new insights into addition questions: 1) what are the cell biological
pathways that work in parallel to classic cell polarity signaling pathway during neural development and 2) how
are rapid cell biological responses during brain controlled by post-translational processes like ubiquitination.

Public health relevance
During neural development, billions of neurons differentiate, migrate, send out axons, and synapse onto their targets in a precisely choreographed sequence. Acquisition of neuronal polarity by progenitor cells or newborn neurons drives many early morphogenetic processes including the exit of these cells from germinal niches, migration initiation to a final laminar position or axon-dendrite specification during neural circuit formation. Despite the discovery of signaling pathways, transcriptional control or epigenetic mechanisms that support polarization, it’s unclear cell biological responses governed by rapid post- translational regulatory mechanisms like ubiquitination control the onset of polarization during development. Identifying such mechanisms can advance our understanding of neuronal migration disorders as well as diseases like pediatric cancers where germinal zone (GZ) exit is compromised. My laboratory uses the Partitioning Defective or Pard, cell polarity signaling complex as a model to understand the molecular and cellular mechanisms controlling cerebellar granule neuron (CGN) neuronal differentiation, polarization, and migration in the developing cerebellum. Our previous work examining the cell biological underpinning of CGN development illustrates that Pard complex signaling regulates multiple events that are coincident with CGN differentiation including GZ exit, radial migration initiation, neuronal adhesion to migration substrates and the cadence of nucleokinesis. We identified a novel mechanism where the Pard3 Pard complex component is post-translationally inhibited in granule neuron progenitors (GNPs) by the Siah2 E3 Ligase. Preliminary studies suggest that Siah2 also regulates CGN GZ exit and radial migration through other targets (e.g. DCC and drebrin) either if cooperation or independently of the Pard complex that will be the topic of this application. We will expand on our preliminary studies by examining how Siah2 controls GZ repulsion via DCC/Pard3 and microtubule-actin interactions with drebrin. We propose two Aims: Aim1: Define how Siah2 and Pard3 regulate DCC-dependent Ntn1 GZ repulsion. Aim 2: Determine how Siah2 regulates microtubule-actin interactions during neuronal differentiation and Lis1-deficient CGNs. These studies will address two important questions in the developing brain: 1) How do guidance mechanisms cooperate with cell adhesion and cell polarity signaling to create optimum migration pathways selections? Investigating this question will provide insight into the GZ exit defects that frequently accompany pediatric cancer like Medulloblastoma. 2) How do cytoskeletal components like actin and microtubules cooperate during migration and how are such interactions regulated in health and disease? Investigating this question will provide insight into how cytoskeletal interactions develop during differentiation and perhaps be exploited to improve neuronal motility in migration disorders.